NNLM Center for Data Science and Delivery of Data Services

National Center for Data Science Abstract Scientific progress is impeded when researchers lack the knowledge and skills to engage in effective data management, reproducible research practices, and meaningful data sharing. A growing number of librarians are providing support for best practices in data management and data science, but there is still tremendous untapped potential across the library community. The Network of the National Library of Medicine (NNLM) Center for Data Science and Delivery of Data Services (NCDS) will coordinate national efforts to provide training and resources to increase capacity among librarians to support two of the National Library of Medicine’s strategic goals: 1) accelerate discovery and advance health by providing the tools for data-driven research, and 2) build a workforce for data-driven research and health. The NCDS team brings a broad set of data skills to this undertaking, as well as experience in successful development of institutional data support and in developing resources for, training, and mentoring librarians on the national level. The NCDS will work collaboratively with the NNLM’s Regional Medical Libraries, Offices and Centers (ROCs), draw upon extensive connections with national data organizations to increase outreach and partner on programming, and assemble an external advisory board with expertise in clinical informatics, bioinformatics, community engagement, machine learning, data ethics, and open science to solicit feedback on our efforts and to maintain awareness of a breadth of current data issues. The NCDS will partner with the National Evaluation Center (NEC) to better understand the needs of the communities we are serving, ensure that training, resources, and support are designed and delivered in ways that meet those needs, generate information on best practices, and evaluate the achievement of the program aims. The proposed education programs will emphasize careful curation of existing content over “reinventing the wheel” in order to build resources such as an online Data Roadmap for self-directed learning and a repository of curricular resources. The NCDS will also focus on support for knowledge application and consolidation, offering courses with coaching to assist in bringing knowledge into practice and training in coding followed by codeathons to consolidate knowledge. Other programming will include a series of unconferences to support community building and development of resources. We will develop a pipeline program to provide data librarianship internships to Library and Information Science and college students from communities currently underrepresented in the profession. The NCDS will take advantage of multiple channels to communicate, including website, blogs, and social media, as well as collaborating with the ROCs and external partner organizations for outreach. The NCDS will use a coordinated, data-driven, innovative approach, to build capacity for providing data services among health information professionals, and in this way facilitate efficient and reproducible research and promote greater collaboration.

Public health relevance
Project Narrative Scientific progress towards improving public health is impeded when researchers lack the skills to collect data in a way that will allow results to be reproduced, analyze data efficiently through use of the best available tools, and share data so that it can be found and used by others for further research. Librarians are well positioned to support these needs for researchers, but often need training in specific skills and support in establishing the library as a provider of data services. The Center for Data Science and Delivery of Data Services of the Network of the National Library of Medicine will coordinate national efforts to provide training and resources for librarians to develop in this area and internships for prospective data librarians from populations underrepresented in librarianship.